Bilingualism as a protective factor of ADRD in American Indian adults: the Strong Heart Study

PROJECT SUMMARY/ABSTRACT
American Indian populations have greater burden of cerebrovascular and Alzheimer’s disease and Related
Dementias (ADRD) comorbidities compared with non-Hispanic White U.S. populations and may also have
greater burden of cognitive decline and dementia. Bilingualism—common in American Indian communities—
may enhance working memory capacity, attentional control, and cognitive reserve, thus reducing cognitive risk.
However, bilingualism is a highly individual experience, and the context of use can modify its cognitive effects.
Factors that may influence this association include age, sex, vocabulary, physical and mental status,
socioeconomic status, culture, and social activity. Comprehensively assessing the relationship between
bilingualism and cognitive performance may be critical to fully understanding ADRD in American Indian adults.
Although the link between bilingualism and cognitive reserve has been studied in many populations,
bilingualism research in American Indian populations has been limited, due in part to critical cofactors related
to their experiences, perspectives, and standardized assessments. Unjust United States (U.S.) federal policies
affecting American Indian people included forced attendance at English-speaking boarding schools where use
of Native languages was punished, and cultural assimilation was prioritized over quality of education. As a
result, bilingualism in American Indian adults who attended such schools may present differently than for other
populations. Indeed, NIA (RFA-AG-23-001) defines bilingualism as “proficiency in two or more languages”,
however no validated, detailed assessment of proficiency exists for U.S. Native languages, or for American
Indian speakers of those languages. Our proposed study will be the first to culturally adapt a language use and
history instrument in a large, heterogeneous American Indian population. In response to RFA-AG-23-001, we
will leverage the Strong Heart Study, a large, longitudinal, heterogeneous, population-based study of aging in
American Indian adults over 3 geographic regions (N=2,500). In this proposed work, we will build on this study,
as well as our prior work, to assess the continuum of bilingualism in American Indian peoples by culturally
adapting the Language History Questionnaire, evaluate bilingualism in American Indians of multiple
generations in association with a detailed cognitive performance battery, and construct conceptual models to
assess intervariable relationships including effect modification and moderation by crystallized cognition. This
project will illuminate questions of public health significance in a vulnerable population that remains
underrepresented in ADRD research, with potential implications for future prevention and treatment strategies.

Public health relevance
PROJECT NARRATIVE American Indian adults have a high burden of Alzheimer’s Disease and Related Dementias- related comorbidities, however, bilingualism—also common among American Indian peoples and communities—may improve cognition and reduce risk. This project will build on the Strong Heart Study, a 30-year cohort of American Indian adults, in coordination with ongoing efforts funded by NHLBI, to assess the broad and heterogeneous continuum of bilingualism in American Indian peoples by culturally adapting the Language History Questionnaire; examine bilingualism in an estimated 2,500 American Indians in association with measures of fluid and crystallized cognition from the NIH Toolbox Cognition Battery, physical and mental status, and cultural factors; and construct conceptual models of intervariable relationships of bilingualism with cognition, including moderation by crystallized cognition. This study will illuminate a major public health concern in an understudied population.